Chemotherapy-induced circadian master clock disruptions and fatigue

Project Summary/Abstract
Understanding the causes and mechanisms underlying circadian rhythm disruptions that are associated with
fatigue during cancer treatment remains unclear. This current deficiency means that successful cancer treat-
ment falls short of its potential and prior quality-of-life remains elusive for patients. Our long-term goal is to im-
prove debilitating behavioral sequelae in cancer patients, thus improving quality-of-life, other comorbidities,
and mortality. Thus, the overall objective here is to establish the potential role of circadian disruption as a fun-
damental pathway by which chemotherapy promotes cancer-associated fatigue. Indeed, robust circadian rhyth-
micity of virtually all physiology is extremely well-conserved; desynchrony of these rhythms leads to negative
health and behavioral consequences. The central hypothesis is that chemotherapy-induced inflammation inhib-
its peripheral (adrenal) clock function contributing to fatigue. The rationale for this work is that circadian cir-
cuitry disruption is an understudied, relevant pathway in psycho-oncology research that could elucidate mecha-
nisms and new, rhythm-focused interventions. One specific aim is proposed to test the central hypothesis us-
ing our novel breast cancer “survivor” mouse model: What is the relationship between peripheral (supplement)
and master (parent) circadian clocks after chemotherapy? Three hypotheses will be tested to answer this
questions. H1: Attenuated glucocorticoid responses to light challenges are correlated with longer SCN re-en-
trainment duration in chemotherapy-treated mice. Corticosterone and melatonin will be quantified during the
light-pulse and jet lag challenges in the parent grant. The rhythmicity of these hormones and their relationships
to wheel running re-entrainment will be assessed. H2: Chemotherapy disruption of clock genes rhythms and
circulating GCs are independent of the HPA axis. Plasma ACTH and corticosterone and clock genes in the
PVN, adrenals, and pituitary will be assessed every 2 h over 24 h. H3: Neuroinflammation drives chemother-
apy-induced GC arrhythmia. Corticosterone rhythms will be analyzed during anti-inflammatory SCN treatment
and cytokines will be quantified in plasma. The proposed research is conceptually innovative because using
circadian approaches is new to psycho-oncology. It is also technically innovative by way of the superior trans-
lational model and the circadian genetic and pharmacological techniques planned. This research will result in
essential new knowledge about how common cancer treatments affect auxiliary clocks, which modulates physi-
ology and behavior (i.e., beyond fatigue). Results will provide much needed evidence to make circadian-based
approaches standard in clinical practice, as well as inform the design of novel circadian-directed pharmacologi-
cal and non-pharmacological interventions. This research is applicable to other cancers and in non-oncological
populations treated with chemotherapy (e.g., stem cell transplant, lupus).

Public health relevance
Project Narrative The proposed research is relevant to public health because the elucidation of new mechanisms (i.e., chronobiology) will increase the understanding of the negative consequences of common drugs on brain and behavior. This mechanistic neuroscience cannot be done in humans. Thus, the proposed research is relevant to part of NCI/NIH’s mission that pertains to reducing cancer-related comorbidities, which in turn, improves health and quality of life.